Elucidating mechanisms of carbon dioxide detection in insects

Project Summary/Abstract
Both a driver of climate change and an ingredient in bubbly drinks, carbon dioxide is a small, volatile
gas imperceptible to humans. Many insect species, however, possess specialized receptors capable
of sensing changes in carbon dioxide levels in their environment. Behavioral responses to carbon
dioxide vary significantly based on species and context. For instance, bees utilize elevated carbon
dioxide levels as a signal to flap their wings to ventilate their hives whereas flies avoid the gas unless
searching for a food source. Additionally, a number of disease-carrying insects such as Anopheles
gambiae (malaria), Aedes aegypti (yellow fever and dengue virus), and tsetse flies (sleeping
sickness) use carbon dioxide as a cue for host detection. Carbon dioxide sensing is critical for many
insect species, yet the underlying molecular mechanisms are not fully understood. Individual receptor
subunits have been identified but their contributions to ligand recognition and channel gating remain
unclear. Uncovering the mechanisms of host carbon dioxide detection would allow for the
development of novel antiviral strategies against some of the world’s deadliest diseases. The
proposed project aims to determine the molecular basis underlying carbon dioxide detection through
three aims. In aim 1, we will determine how to express and purify carbon dioxide receptors. In aim 2,
we will obtain a structure of the Aedes aegypti carbon dioxide receptor and finally in aim 3, we will
compare ligand binding pockets of two species, Aedes aegypti and Drosophila melanogaster. By
understanding species-specific binding pocket differences, we can develop compounds that target the
receptors of disease-carrying insects with high specificity. Together, these three aims will establish the
molecular mechanisms underlying carbon dioxide detection and widen strategies for combating
vector-borne diseases.

Public health relevance
Project Narrative Insects can detect a wide array of scents that are imperceptible to humans, including carbon dioxide, which mosquitoes use to locate hosts. My project applies structural biology and biochemistry to uncover the molecular mechanisms of insect carbon dioxide detection. This research aims to enhance our understanding and inform novel strategies to combat diseases such as Zika, Yellowfever, and Dengue virus.